EFFECT OF DEHYDROEPIANDROSTERONE ON BONE DENSITY IN PREMENOPAUSAL WOMEN

We will test two hypothesis. First, that DHEA therapy reduces elevated markers of bone turnover. Second, that DHEA prevents the accelerated bone loss in women treated with GnRH agonists for endometriosis.